BID Core

Behavioral Intervention Development (BID) Core Abstract
The overall goal of our Midwest Roybal Center for Health Promotion and Translation is to
advance the science, translation, and practice of health promotion programs for older adults at
risk of AD/ADRD. The BID Core will enable us to achieve that goal by identifying talented
investigators and providing them with mentoring, support, and incentives that will enable them to
test impactful interventions. Interventions that we support will be highly feasible for immediate
translation and implementation into practice while advancing science in our areas of thematic
focus. Our thematic foci for this renewal application include: a. Develop and test principle driven
interventions to increase physical activity (PA) among older adults at risk of ADRD; b. Design
interventions to maintain and/or enhance cognitive function and mobility; c. Harness technology
to promote healthy cognitive aging and to improve the scalability of existing interventions for
cognitive health including PA, diet, and stress reduction; d. Target mechanisms of behavior
change (MOBC) to promote and sustain behavioral and lifestyle change. To achieve these aims,
we will issue annual calls for internal and external investigators to apply to a national
competition that will seek to identify the most promising, potent and scalable applications that
address these foci and have the potential to advance science in at least one of these areas. We
will require that all applications use and identify a MOBC and that the specific aims of each
application identify a hypothesized mechanism of action (MOA). Successful applications will be
required to have adequate statistical power to achieve interpretable results. The two proposed
Year One trials meet these criteria. Dr. Motl's Stage I trial extends his Life Light Physical Activity
(LPA) intervention that was tested with persons with Multiple Sclerosis to persons with
Parkinson's Disease (PD) who are at high risk for dementia. LPD combines Social Cognitive
Theory (SCT) counseling with PA that occurs while performing Activities of Daily Living.
Endpoints are step counts, improved cognitive function, and MR imaging. Dr. Aquinaga's Stage
II trial builds on her current trial of a combined dance and diet intervention for older Latinos who
are at high risk for AD/ADRD. Since evidence indicates a combination of aerobic and strength
exercises have the largest impact on cognition, she will test the benefit of adding strength
training to her existing intervention. Outcomes are executive function and multiple biomarkers.
MOA are changes in Insulin growth factor 1 and homocysteine levels produced by the strength
training. Both trials have anticipated pathways to advance through the NIH Stage Model stages.

Public health relevance
Behavioral Intervention Development (BID) Core Narrative Our proposed UIC Midwest Roybal Center for Health Promotion and Translation seeks to turn the findings of behavioral research interventions into real-world ways of improving the physical and brain health and quality of life of older adults at risk of Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD). Our BID Core will enable us to achieve that goal by identifying talented investigators and providing them with mentoring, support, and incentives that will enable them to test impactful interventions. Interventions that we support will be highly feasible for immediate translation and implementation into practice while advancing science in our areas of thematic focus.